Racial and Socioeconomic Differences in Chronic Low Back Pain

Project Summary/Abstract
Low back pain is one of the most common disabling conditions in the world. The worldwide point prevalence of
activity-limiting (acute and chronic) low back pain is approximately 12%, which equates to approximately 933
million people globally suffering with low back pain at any given time. Chronic low back pain (cLBP) refers to
pain lasting at least twelve weeks or longer, and it is consistently among the top five most common reasons for
primary care physician visits. Although some individuals with cLBP have clear pathoanatomic causes of pain,
the vast majority of cLBP is “non-specific” and is not accompanied by readily identifiable pathology of the spine
or related tissues. Without a clear target for treatment of cLBP, effective pain management can be difficult to
achieve. Because objective measures of disease activity have not consistently been strong predictors of clinical
symptoms, cLBP provides an excellent model for investigating the influence of social determinants such as racial
background and social stress on the progression of pain and disability over time. During our previous funding
cycle, we found evidence that non-Hispanic Black (NHB) individuals with cLBP reported significantly greater pain
severity and disability than their non-Hispanic White (NHW) counterparts. In addition, we observed racial
differences in pain-related psychosocial and biological measures, which were significantly associated with racial
group disparities in cLBP severity. Furthermore, racial disparities in cLBP were exacerbated by low
socioeconomic status (SES), such that NHBs with low SES demonstrated the absolute greatest burden of cLBP.
While our findings demonstrate clear racial differences in cLBP severity and disability between NHBs and NHWs,
the findings are largely indirect and cross-sectional. Differences in how cLBP progresses over time between
NHBs and NHWs, as well as factors that contribute to cLBP progression, remain poorly understood. Among the
multiple factors that inevitably contribute to racial group differences in cLBP, social stress represents a potentially
important social determinant of greater cLBP severity and disability in NHBs. For this proposed follow-up study,
we will elucidate the contribution of social stress and its biological consequences (i.e., allostatic load) to racial
group disparities in cLBP by prospectively assessing the two-year progression of clinical pain and disability, as
well as pain-relevant psychosocial functioning among NHBs and NHWs with cLBP. We will use minority stress
theory to guide the study aims related to the progression of racial group disparities in cLBP; however, we will
also use a recently developed resilience framework to guide inclusion of psychosocial resilience factors that may
mitigate the effects of social stress on cLBP in NHBs and/or NHWs.

Public health relevance
PROJECT NARRATIVE The impact of social stressors such as economic hardships, inter-personal violence, social isolation, unstable access to healthcare, and other major life events/daily hassles on the progression of chronic low back pain (cLBP) remains poorly understood. The goal of this project is to elucidate the influence of social stressors, and their biological consequences (i.e., allostatic load), on cLBP by prospectively assessing the two-year progression of clinical pain and disability among people residing in the greater St. Louis MO and Nashville TN metropolitan areas.